10th International ICAPS Conference 2016 on Lung Cancer Prevention with a Consensus Conference on Early Detection and Prevention of Lung Cancer

PI: Brown, Powel H. PROJECT SUMMARY/ABSTRACT The International Cancer Prevention Society (ICAPS), is hosting the 10th Annual ICAPS Conference in Vienna, Austria, on December 2-3, 2016. This conference is being chaired by Dr. Powel H. Brown, MD, PhD, ICAPS President and chair of Clinical Cancer Prevention at the University of Texas M.D. Anderson Cancer Center, which will be the applicant organization. This meeting will present cutting-edge discoveries in lung cancer prevention, facilitate interaction among scientists, stimulate research collaborations, and introduce in-training scientists to the field of cancer prevention. The meeting will be held at smoke-free, fully accessible conference facilities, and will immediately precede the 17th World Conference on Lung Cancer. Formal presentations given by international leaders in lung cancer prevention, oral abstract presentations, poster sessions, panel discussions, and interactive sessions for junior researchers will be included. A unique feature of the 2016 ICAPS meeting is the consensus development session which will result in the development and publication of consensus recommendations for prevention, risk assessment and early detection strategies for lung cancer. The specific aims of the 2016 annual ICAPS Conference are: (1) Present novel cancer prevention and early detection strategies for lung cancer. (2) Facilitate interaction among cancer prevention scientists. These interactions will stimulate research collaborations, introduce scientists and clinicians currently in training to the cancer prevention community. (3) Evaluate current evidence relating to lung cancer prevention, and produce consensus recommendations for lung cancer prevention and early detection. We request funding support from the NCI to partially off-set travel costs of US-based faculty, students, fellows, and early investigators. The 2016 ICAPS Conference will bring together cancer prevention researchers from around the world and provide a conducive and interactive environment to promote the scientific exchange of ideas, and will thereby lead to advances in risk assessment, screening and prevention strategies for individuals at risk for lung cancer. Page 1

Public health relevance
PI: Brown, Powel H. PROJECT NARRATIVE The 2016 ICAPS Conference has been planned by Dr. Powel Brown, president of ICAPS, and the ICAPS Organizing Committee, will be held in Vienna, Austria under the title of “10th International ICAPS Conference 2016 on Lung Cancer Prevention with a Consensus Conference on Early Detection and Prevention of Lung Cancer.” As lung cancer is the leading cause of cancer-related death and is the second most diagnosed cancer in the United States (Siegel et al, CA Cancer J Clin 2016), and both new cases and deaths related to lung cancer are high around the world, this conference has a high level of relevance to public health, and offers a venue for potential collaborations leading to novel interventions in the future. The major goals of this meeting are to foster interaction and collaboration between early and/or minority investigators with experts in cancer prevention, to discuss the current state of lung cancer early detection and prevention science, to produce a concensus paper that will make recommendations for current lung cancer screening and prevention, and to propose a plan for the next lung cancer prevention clinical trial. Page 1